SIM2 Regulation of Mitochondrial Dysfunction in Down Syndrome

SUMMARY
Down Syndrome (DS) is the most common type of genetic disorder affecting approximately 1/750 newborns in
the United States each year. DS is caused by an extra copy of all or part of the long arm of human chromosome
21 (HSA21). The DS phenotype is highly complex and variable including common phenotypes such
characteristic facial features, intellectual disability, skeletal muscle weakness and variable phenotypes including
heart defects, increased incidence of Alzheimer’s disease, type 2 diabetes and obesity. It is becoming clear that
mitochondrial dysfunction and oxidative stress are major underlying factors in DS-related pathologies.
Impairment in respiration, ATP production and mitochondria structure have been described in skeletal muscle
and central nervous system in DS patients and mouse models. However, the mechanism driving mitochondrial
dysfunction in DS is still not clear. We have shown that singleminded 2 (SIM2), a gene that was initially cloned
on HSA21 and a member of the bHLH/PAS family of proteins, is expressed in skeletal muscle cells and regulates
whole system metabolism. Our recent results using gain and loss function cell lines and mouse models have
found that SIM2 regulates mitochondrial function, not as a classical transcription factor, but by interacting directly
with mitochondria and modulating mitochondrial respiration (MRC), potentially through interaction with the
mitochondria respiratory chain. Based on these new results, we hypothesize that increased expression of Sim2
in DS skeletal muscle promotes mitochondrial activity, resulting in increased oxidative stress and mitochondrial
dysfunction. To address this hypothesis we propose three Specific Aims. In Aim 1, we will determine the role
of SIM2 in the mitochondrial respiratory complex in DS. We will also define the physical basis for, and functional
outcomes of, interactions between SIM2 and the mitochondria respiratory chain complex in metabolism. In Aim
2, we will determine the role of Sim2 in DS-associated skeletal muscle dysfunction by crossing the well-
established DS mouse model, Dp(16)1Yey/+ DS, with whole body Sim2+/- knockout mice. In addition, we will
also determine the impact loss of Sim2 has on mitochondrial turnover and structure by crossing the mito-QC
mouse model with Sim2+/- mice. In Aim 3, we will take advantage of the recent advances in synthetic antisense
oligonucleotide (ASO) technology to develop and test in cell culture and DS mouse models using a Sim2 ASO
drug for DS. We expect results from these studies will help define the mechanism of mitochondrial dysfunction
in DS.

Public health relevance
NARRATIVE Mitochondrial dysfunction and oxidative stress are major causal factors promoting Down Syndrome pathologies. Determining the interconnections between SIM2 and mitochondrial activity will provide a better understanding of the pathways driving mitochondrial dysfunction in Down Syndrome and a novel target for therapeutic treatment.